Assay Guidance Manual

The AGM program conducted multiple workshops during this period:
-AGM Workshop on DNA-Encoded Libraries for Lead Discovery (Day 1 on September 1, 2021: https://videocast.nih.gov/watch=42626; Day 2 on September 2, 2021: https://videocast.nih.gov/watch=42628)
-Assay Guidance Workshop for Cell-Based Assays and Lead Discovery (Day 1 on November 16, 2021: https://videocast.nih.gov/watch=44132; Day 2 on November 17, 2021: https://videocast.nih.gov/watch=44130)
-Assay Guidance Workshop for High-throughput Screening and Lead Discovery at SLAS 2022 in Boston, MA on February 2022
-Assay Guidance Workshop on 3D Tissue Models for Antiviral Drug Development (Day 1 on June 7, 2022: https://videocast.nih.gov/watch=45399; Day 2 on June 8, 2022: https://videocast.nih.gov/watch=45401)

An SLAS Discovery special issue Assay Guidance Manual for Drug Discovery: Robust or Go Bust and an SLAS Technology special collection Assay Guidance Manual for Drug Discovery: Technologies That Matter were compiled and published in December 2021. An SLAS Electronic Laboratory Neighborhood e-zine article on the AGM issues of the SLAS journals was also published online. An SLAS webinar, and 2 podcasts were also conducted which gave insights about these collections.

Two Editorials were published by the AGM team in December 2021 that were part of the AGM special issue and collection in SLAS journals:
-Markossian S, Coussens NP, Dahlin JL, Sittampalam GS. Assay Guidance Manual for Drug Discovery: Robust or Go Bust. SLAS Discov. 2021 Dec;26(10):1241-1242. doi: 10.1177/24725552211054044. PMID: 34813395.
-Markossian S, Coussens NP, Dahlin JL, Sitta Sittampalam G. Assay Guidance Manual for Drug Discovery: Technologies That Matter. SLAS Technol. 2021 Dec;26(6):553-554. doi: 10.1177/24726303211056338. PMID: 34813399.

New Assay Guidance Manual chapter added this year:
-Hoare SRJ, Hughes TE. Biosensor Assays for Measuring the Kinetics of G-Protein and Arrestin-Mediated Signaling in Live Cells. 2021 Sep 1. Available from: https://www.ncbi.nlm.nih.gov/books/NBK574243/